The role of C. neoformans Hog1 and its effectors in translatome reprogramming

Abstract
Cryptococcus neoformans is an environmental fungus and opportunistic pathogen of people with compromised
immune systems that causes an estimated 181,000 deaths annually. A key step in C. neoformans pathogenesis
is adaptation to the host, which is mediated by several signal transduction pathways. Translatome
reprogramming, changes in protein synthesis, is a key output of these signal transduction pathways that allows
C. neoformans to rapidly fine-tune the stress response, and defects in this process are associated with reduced
virulence. The Hog1 p38 MAP kinase (MAPK) module is one signaling module that mediates this process, though
the mechanism and effectors by which Hog1 mediates reprogramming are unknown in C. neoformans. We
propose to identify the molecular basis of Hog1 activation, and generate a high throughput characterization of
its interactome. We also found that another translatome regulatory pathway, the Gcn2 pathway, is differentially
regulated in hog1∆, and aim to evaluate the implications of this change in both translatome reprogramming as
well as virulence. Thus, we hypothesize that Hog1 mediates changes to a broad interactome via its kinase
activity, and that crosstalk with the Gcn2 pathway masks more severe defects in stress tolerance and
virulence in hog1∆. We will be testing two specific aims: (1) Determine the mechanism by which Hog1 regulates
stress responses in C. neoformans, and (2) Evaluate whether increased eIF2α phosphorylation compensates
for loss of Hog1. This project is significant as it will elucidate the mechanism of reprogramming by Hog1, will
identify effectors that could be targeted to inhibit this process, and will also examine a convergence point between
two major signaling pathways. The overall goal of this research training plan is to equip the candidate with the
necessary skills to answer these questions, and to provide them with relevant training to establish themselves
as a successful academic investigator studying fungal pathogenesis and stress adaptation. These goals will be
accomplished under the guidance of a sponsor and thesis advisory committee, with the help of training
opportunities and equipment provided by the University at Buffalo, and through professional development
opportunities at conferences and workshops.

Public health relevance
Narrative This proposal will investigate how the human pathogen Cryptococcus neoformans senses host body temperature, responds, and establishes an infection leading to disease. The goal of this work is to better understand the molecular mechanisms by which C. neoformans communicates stress signals to the protein synthesis machinery, the ribosome. Elucidation of these mechanisms may allow for process to be targeted to prevent successful infection.